MECHANISM OF ANGIOTENSIN II MODULATION IN ESSENTIAL HYPERTENSION

Determine whether blood pressure response to a low dose long infusion of angiotensin II (ANG II), in subjects pretreated with long-term converting enzyme inhibition (CEI), is greater with patients with renin dependent, non-dependent, modulating essential hypertension.